Towards equitable early identification of autism spectrum disorders in females

PROJECT SUMMARY/ABSTRACT
Screening tools for autism spectrum disorder (ASD) show poor predictive performance in practice, particularly
for females, which may arise due to sex-related measurement bias of screening questionnaires, and lack of
precision in capturing the variability in early symptom profiles of ASD. Computational approaches to
characterize heterogeneity and assess and account for sex-related measurement bias in early ASD symptoms
may identify ASD risk profiles that can be clinically actionable in practice. The candidate's long-term goals are
to enhance goals quality of life for children with ASD and their families by lowering the age of diagnosis,
especially in females missed by traditional screening methods. The research and training described in this K23
application will build on the candidate's existing expertise, adding conceptual and methodological skills needed
to develop and implement a novel screening approach that will more precisely identify ASD risk in a
community-based sample. Aim 1 evaluates the extent of sex-based measurement bias in measures shown to
capture clinically-relevant variability in early ASD traits in a sample of 3,000 children between 17-25 months
recruited from a community research registry. Aim 2 applies computational approaches to model dimensional
variability in early ASD symptoms and identify subgroups of risk in the same sample that are hypothesized to
vary on clinical outcomes at 36 months. Aim 3 takes a dissemination and implementation (D&I) science lens to
assess parent and provider views on screening practices to identify facilitators and barriers to change via
qualitative interviews (Pediatrician N=20; Parent N=40). This project is in line with NIMH Strategic Plan Goal 2
to “examining mental illness trajectories across the lifespan.” The candidate is a clinical psychologist and
Assistant Professor at the University of Minnesota, with expertise in characterizing sex differences in early
ASD trajectories. The proposed K23 application will provide the candidate with the training needed to develop
new knowledge and skills in conducting community-based screening for ASD, computational modeling of
heterogeneity, and dissemination and implementation science. Mentors Dr. Damien Fair, Jed Elison, and
Timothy Beebe possess the expertise and mentoring skills to support these training and scientific aims. This
will position the candidate to build an independent clinical-translational research program focused on improving
the precision of early screening for ASD to enable precision medicine for early ASD concerns that are
equitable by sex. Training will occur in an exceptional scientific environment in the Department of Pediatrics at
the University of Minnesota and the newly established Masonic Institute of the Developing Brain.

Public health relevance
PROJECT NARRATIVE This K23 proposal entitled, Towards Equitable Early Identification of Autism Spectrum Disorder in Females, will test the hypothesis that using computational approaches to identify sex-related measurement bias and characterize heterogeneity in early ASD symptoms will identify ASD risk profiles that can be clinically actionable in practice. Training goals focused on conducting community-based screening for ASD, computational modeling of heterogeneity, and dissemination and implementation science, under the mentorship of Dr. Damien Fair, Dr. Jed Elison and Dr. Timothy Beebe will support the career development of Dr. Catherine Burrows, an Assistant Professor at the University of Minnesota. The work herein promises to elucidate novel, clinically actionable screening practices to lower the age of identification of ASD-related concerns.